The role of chronic migraine as an early biomarker of Alzheimer's Disease

Project Summary / Abstract
Alzheimer’s Disease (AD) is a devastating neurodegenerative disease characterized behaviorally by memory
loss typically later in life and is ultimately fatal. Early detection of potential AD biomarkers in asymptomatic
patients will promote disease prevention strategies. Migraine disorder is a disabling chronic disease condition
that affects over 15% of the general population. Clinical reports show that AD is prevalent in individuals with a
history of migraine, and that the incidence of AD is significantly higher in those that suffer from migraine at a
younger age. There is a lot of overlap in the CNS neuroinflammatory pathways involved in the pathogenesis of
both migraine disorders and AD, however, a mechanistic and behavioral understanding of the molecular
contributors to migraine-induced AD remains unknown. A major barrier to progress is that the AD field has
not reverse translated this increased AD incidence in migraine patients to preclinical animal models. Here, we
show that transgenic AD mice exposed to chronic migraine via a series of injections with the migraine-causing
drug, Nitroglycerin, don’t learn as well as non-migraine AD mice during a cognitive task. Additionally, we show
increased amyloid accumulation in the brains of AD mice treated with Nitroglycerin. The central hypothesis of
this proposal is that chronic migraine accelerates the development of AD pathology and associated cognitive
decline in preclinical AD mouse models. In Aim 1, we will determine how chronic migraine affects multiple
domains of cognition in a preclinical mouse model of AD. We will utilize an identical test that is currently used
in the clinic to diagnose AD. In Aim 2, we will work with the IUSM Biomarkers Core to run spatial
transcriptomics and proteomics in order to determine whether migraine progresses the activation of particular
gene and protein expression patterns known to be altered in AD transgenic mice. We will measure key
pathological features of both AD and migraine including amyloid plaques, multiple forms of tau, and CNS
inflammatory markers in hippocampus, an area of the brain known for its role in spatial learning and memory
processes. In both Aims, we will assess for potential sex differences. Indeed, female patients with a history of
migraine have a much higher risk of developing AD compared to age-matched males. This area of research is
highly novel to the AD field in that we are the first to reverse translate the increased human AD incidence in
chronic migraine sufferers to preclinical animal models and the first to identify overlapping transcriptome and
proteome targets associated with both diseases. Based on the spatial-omics data collected here, we will have
the necessary rationale in our future R01 application to determine whether targeting various proteome
biomarkers restores cellular function in various regions of the brain including hippocampus, frontal cortex, and
in areas of the brain that greatly contribute to the onset of migraine and AD pathology including the locus
coeruleus. A large percentage of the human population suffer from migraine disorders and will greatly benefit
from this area of work that will allow for us to identify early biomarkers of AD in chronic migraine sufferers.

Public health relevance
Project Narrative Due to our aging population, an estimated 6.7 million Americans aged 65 and older are living with Alzheimer’s Disease (AD), and this number could more than double by 2060 without the development of medical breakthroughs to prevent, slow, or cure AD. The incidence of AD is much higher in individuals with a history of migraine, and this incidence is even higher in those that suffer from migraine at a younger age. A mechanistic and behavioral understanding of the molecular contributors to migraine-induced AD will lay the foundation for the discovery of novel early biomarkers and therapeutic interventions for AD.